Connecting Single-Cell Signaling Dynamics to Multicellular Decision Making

SUMMARY Cures for many diseases and injuries have remained elusive because the systems they affect are highly adaptable multicellular collectives that harness biochemical communication to reprogram themselves to circumvent our treatment strategies. The goal of my research program is to identify how single cells interpret their environments and modulate their behaviors to control these multicellular decisions. Our current understanding of this connection has been limited due to the conceptual and technological challenges presented by connecting the small-scale, fast dynamics inside single cells to larger-scale behaviors unfolding over hours and days in cellular populations. During this award, we will address these challenges and focus on resolving several key gaps in our understanding, specifically (1) identifying single-cell regulatory mechanisms for modulating population-wide behaviors and (2) elucidating how the interplay between signaling and mechanics drives cellular populations to work together to remodel themselves. To enable us to directly link single-cell dynamics to population-wide decision making, our funded grant supports developing and implementing new technologies for simultaneous quantitative visualization and control of intra- and intercellular biochemical dynamics driving these decisions. This equipment supplement is requesting funding to support a high-throughput, highly-reproducible imaging system to support the screening of genetically-encoded tools and imaging conditions to interrogate these signaling dynamics. The behaviors we seek to understand occur over hours and days, and adapting tools for quantifying and controlling these dynamics to new questions requires a high-throughput approach. The tools we develop in these systems to link signaling dynamics to population behaviors will also enable us to interrogate these behaviors and develop models of these behaviors with real predictive power. This supplement will both allow us to develop a new predictive understanding of the single- cell dynamics used to coordinate collectives and by demonstrating we can control these behaviors ourselves, laying the groundwork for reprogramming these behaviors for transformative new disease and injury treatments, as well as develop well-characterized toolbox for interrogating and controlling these behaviors in multiple model systems that we will disseminate to the broader medical science community.

Public health relevance
NARRATIVE Cells work together and make group decisions in health-related systems ranging from bacterial biofilms to neuronal networks to human organs to cancer tumors by sending each other biochemical signals. This proposal’s goal is to determine how the dynamics of these biochemical signals, generated by single cells, coordinate decision making in multicellular collectives. This work is relevant to the NIH's mission because this fundamental research into how these signals are responsible for decision making in a whole population of cells will lay the groundwork for targeting these signals as part of new disease and injury treatments.